Accelerating Medicines Partnership-Autoimmune and Immunologic Disease Tissue Research Core Admin Supplement: Preclinical Studies in Sjogren's

PROJECT ABSTRACT
Sjögren’s syndrome (SS) is an incapacitating rheumatic disease typified by severe dry eyes and mouth, often
including arthritis, debilitating fatigue, pulmonary involvement, neuropathy, vasculitis and malignant lymphoma.
The personal and economic burdens ($35 billion/year in the US) are high, and there is no effective biologic
therapy. Lack of understanding of basic disease processes, molecular underpinnings of patient heterogeneity,
and effective diagnostic biomarkers have hindered the development of effective biologic therapies and conduct
of successful clinical trials. This is especially true for patients lacking anti-Ro antibodies (Ro– SS) who require a
salivary gland biopsy for classification. We are in a unique position to study the differences between Ro+ and
Ro– SS. In our carefully phenotyped cohort, nearly 40% of SS patients meeting current classification criteria lack
diagnostic anti-Ro autoantibodies. Our Ro– SS cases have more glandular, articular, and pulmonary involvement
than Ro+ SS cases, yet these patients are often not diagnosed by rheumatologists or included in clinical trials.
Herein, we leverage our multidisciplinary team of investigators with expertise in rheumatology, immunology,
genomics/genetics, as well as our carefully phenotyped cohort of 668 SS cases and 925 non-SS sicca patients
to address these deficiencies. The project is based on compelling preliminary data identifying common and
unique features in both Ro+ and Ro– SS groups and will study a common set of 60 Ro+ SS cases, 60 Ro– SS
cases, and 24 healthy controls. Aim 1 will develop and apply an autoantibody-based diagnostic test for Ro– and
Ro+ SS and leverage salivary gland proteomics, spectral flow cytometry, imaging mass cytometry, and functional
studies to clarify the role of T and B cell subsets in disease. Aim 2 will employ single cell RNA-seq of PBMC and
sorted cells studied in Projects 1 and 2, identify chromosomal interactions in primary salivary gland epithelial
cells, study functional effects of Ro+ and Ro– SS risk alleles and long non-coding RNAs using CRISPR
interference or activation for enhancers, and use feature selection and machine learning to identify sources of
heterogeneity between Ro+ and Ro– SS.

Public health relevance
PROJECT NARRATIVE Patients with Sjögren’s syndrome (SS) suffer from severe dry eyes and mouth, pain, fatigue, arthritis, neuropathy, pulmonary involvement, and B cell lymphoma. Barriers to successful clinical trials and development of effective biologic therapies include: i) lack of a non-invasive diagnostic test for 35-40% of patients who lack anti-Ro autoantibodies, and ii) poor understanding of disease pathophysiology and molecular basis of patient heterogeneity. This Center will develop a non-invasive diagnostic test for Ro– SS, determine the cell types and novel genetic associations contributing to pathophysiology, and decode patient heterogeneity using multi-omics datasets, resulting in new therapeutic targets, biomarkers and tools for monitoring disease activity.